Intracellular Cargo Transport in Toxoplasma Gondii

PROJECT SUMMARY
Intracellular cargo transport is a vital and ubiquitous cellular process that occurs in all eukaryotic cells. However,
the mechanisms of cargo transport have only been extensively investigated in a small number of “model” species,
leaving a large knowledge gap in our understanding of the mechanisms in other eukaryotic groups. Studies in a
wider range of species will ultimately lead to a more comprehensive understanding of the mechanisms, functions
and evolutionary origins of these cellular processes. The overall goal of this proposal is to characterize how the
actin cytoskeleton controls cargo trafficking in Apicomplexan parasites, a large phylum that contains over 5,000
species, many of which have significant medical relevance, using Toxoplasma gondii as a model organism. T.
gondii is a genetically tractable organism with straight-forward cell culture and amenable to live-cell and super-
resolution microscopy, so it is well suited for the proposed studies. We will employ a range of intradisciplinary
methods including parasite cell biology and genetics, live cell microscopy and in vitro single molecule biophysics
to study this cellular process. This study builds on previous data demonstrating that the organization of the
endomembrane system in T. gondii is regulated by filamentous actin and an unconventional myosin motor,
MyoF. Of relevance for the current study, we showed that vesicle formation at the trans-Golgi network and vesicle
transport are dependent on this acto-myosin system, despite the parasite having a simplified repertoire of actin-
binding proteins (ABPs) and is missing several conserved actin regulators, including Arp2/3 complex, WASP-
family proteins and bundling proteins, such as fascin. Three lines of evidence strongly indicate that MyoF and
actin execute these cellular processes using a novel mechanism of action: (1) In vitro studies of actin’s
polymerization properties show that this actin isoform is tuned for rapid disassembly and turnover; (2) Live cell
imaging demonstrated that F-actin in the parasite cytosol is highly dynamic and undergoes continual
rearrangement and does not to form stable tracks on which MyoF could transport cargo; and (3) MyoF does not
associate directly with membrane-bound cargo. Instead, MyoF is an organizer of the actin cytoskeleton and loss
of this protein results in the aberrant accumulation of actin adjacent to the Golgi. Based on this data, we propose
that both vesicle formation and transport are powered by a membrane-associated actin-nucleator and that MyoF
and other newly identified actin bundling proteins control actin organization. We will test this model by creating
inducible knockdown parasite lines, and defining the roles of these ABPs in vesicle formation and transport, and
actin organization. We will reconstitute the activity of these proteins in vitro and determine how each protein
influences actin filament polymerization and bundling, both individually and in combination. Defining how this
actin isoform, with novel polymerization properties and a reduced set of ABP’s, mediates protein trafficking will
be highly valuable in characterizing protozoan specific aspects of this cellular process and will lead to a more
comprehensive understanding of general eukaryotic cargo transport mechanisms.

Public health relevance
PROJECT NARRATIVE Toxoplasma gondii is the causative agent of Toxoplasmosis, a life-threatening disease in immunocompromised individuals. In this proposal, we will focus on understanding how the parasites’ actin cytoskeleton drives intracellular cargo transport. Impaired protein trafficking through the secretory system results in parasite death so identification of novel proteins in this pathway are potential targets for anti-parasitic drug development in future studies.